Drug targeting the dynamics of opioid systems in alcohol dependence

PROJECT SUMMARY
Alcohol use disorder (AUD) is a serious condition with severe medical and societal consequences.There has
been little progress in medical treatment over the past decades. We are taking a translational approach and have
established an animal model, where alcohol-dependent rats in various stages of abstinence are subjects of
investigation. The neuronal target is the opioid systems and the opponent hypothesis. We propose that the initial
euphoric effects are channeled through the enkephalin/mu-opioid receptor (MOP) and the later developing
negative reinforcement (craving) is related to activity at the dynorphin/kappa-opioid receptor (KOP). In fact, the
MOP antagonist, naltrexone is a FDA-approved agent with indication to reduce relapse. KOP antagonists are
entering clinical trials in different neuropsychiatric conditions. We have chosen CERC-501 as index drug, being
reversible and apparently well tolerated in clinical examination. After behavioral recordings, brain specimens will
be dissected and form a “brain bank” for further analysis. A focus of interest is the central nucleus of the amygdala
(CeA), and the circuitry presenting MOP and/or KOP. Selected specimens will undergo superresolution
microscopy (quantitative Single Molecule Localization Microscopy, qSMLM). A pilot study showed that already
an acute dose of EtOH disrupts localization of MOP and KOP, an effect blocked by naltrexone. How EtOH affects
receptor mobility in the plasma membrane, receptor clustering (homo- and hetero-dimers) and association with
protein- and lipid-rich membrane domains will be studied by fluorescence correlation spectroscopy (FCS). As
with qSMLM resolution is achieved at the single-molecule level. Both technologies will be used to study co-
localization of receptors with proteins of relevance for the signaling cascade. We hypothesize that EtOH perturbs
the dynamic selforganization of signaling domains harboring MOPs and KOPs, that distinct alterations in
mechanisms controlling MOP vs KOP organization develop during chronic EtOH exposure. With OP antagonists
innate MOP and KOP signaling complexes are stabilized at the nanoscale level. Focused studies of these
mechanisms will provide critical new insight into molecular mechanisms through which EtOH-induced receptor
disruptions may be prevented or reversed. The commensurate importance of the two opioid systems may vary
between individuals and influence the choice of personalized therapy with OP antagonists. Studies will include
the N40D MOP genotype known to affect the behavioral phenotype and sensitivity to naltrexone.

Public health relevance
NARRATIVE Alcohol use disorder (AUD) is a serious condition, which we study in a rat model and in cell culture. We search conditions for prevention of relapse with the approved drug naltrexone mainly acting on the enkephalin/MOP receptor and with agents acting on the dynorphin/KOP receptor systems. Comprehensive analysis of changes in circuitry in the central nucleus of the amygdala are guided by super-resolution imaging and mechanistic studies at a molecular level.